UNC Neuroscience Center Research Cores: Microscopy

PROJECT SUMMARY- MICROSCOPY CORE
The Microscopy Core provides state-of-the-art microscopes, image analysis, expert consultation, and
advanced training in support of Qualifying Investigators and other NINDS-priority investigators at UNC. The
Core consists of a microscopy expert, a suite of microscope systems, image analysis tools, and associated
resources for advanced microscopy. The Microscopy Core leverages support from the NINDS Center grant
with support from an Intellectual and Developmental Disabilities Research Center (IDDRC) from NICHD
(awarded to the Carolina Institute for Developmental Disabilities; CIDD) to enhance the research programs of
neuroscience faculty working in NINDS priority research areas.